Identifying complex modes of adaptation from population-genomic data

Project Summary
Low-cost DNA sequencing has provided researchers with abundant genomic data in which to search for the
unique footprints left by natural selection. However, many nonadaptive forces can obscure these signals, making
it important to develop statistical methods that can account for multiple factors that influence genetic variation.
My research in this area focuses on the design and application of statistical approaches for identifying regions
undergoing positive selection, which increases the frequency of beneficial alleles in a population, and balancing
selection, which maintains the frequency of distinct alleles in a population. During the past four years of my MIRA
ESI, my group contributed to a number of methodological advances, including designing the first likelihood
methods to detect positive selection from haplotype distributions, state-of-the-art likelihood methods to detect
ancient balancing selection within and across species, the first likelihood method to detect positive selection by
adaptive introgression, and the first machine learning method to detect positive selection by explicitly modeling
genomic autocorrelation. Applications of our methods to empirical data led to several novel insights, including
evidence of convergent positive selection in Europeans and East Asians, positive selection at olfactory genes
that affect communication and behavior in New York City rats, and balancing selection at venom genes that may
influence predator-prey coevolutionary dynamics in rattlesnakes. During the next five years, I propose to develop
improved statistical and machine learning approaches to detect complex modes of adaptation by leveraging
information about how different evolutionary forces simultaneously shape the distribution of genetic diversity
around adaptive sites. In particular, my future research program will be subdivided into several interrelated goals:
designing likelihood frameworks to identify positive and balancing selection while accounting for genomic,
temporal, and spatial autocorrelations; developing methods to identify regions that underwent complex positive
and balancing selection from ancient variation; introducing signal processing approaches to extract features from
images of genomic variation for use in machine learning models of adaptation; and building innovative domain
adaptation procedures to circumvent genetic and demographic parameter uncertainty when training machine
learning predictors of adaptation. Availability of these methods will empower researchers to address important
questions about adaptation in model and non-model organisms from ancient and contemporary samples,
increasing inclusivity in the field, and thereby broadening our knowledge about adaptation. Further, we will apply
these methods to answer or revisit key evolutionary questions about the roles of different adaptive mechanisms
in primates, rodents, snakes, insects, plants, and other organisms with complex or unknown demographic
histories. Advantages of these studies are two-fold, in that they will yield powerful new approaches for identifying
signatures of diverse modes of adaptation from genomic data, as well as elucidate evolutionary forces underlying
the acquisition of adaptive phenotypes, such as those involved in disease resistance and pathogen defense.

Public health relevance
Project Narrative Natural selection is an important evolutionary force that enables humans to adapt to new environments and fight disease-causing pathogens. However, the unique footprints of natural selection in our genome can be buried beneath those left by other evolutionary forces. Thus, by leveraging information about multiple evolutionary forces, we can identify signatures of natural selection in the human genome, and ultimately determine its role in human adaptation and disease.